CORE--DATA ANALYSIS

Dr. Anders H. Andersen will direct the Data Analysis Core. Dr. Andersen has over 15 years experience in biomedical signal and image data analysis, especially in the area of MRI and fMRI data. He is familiar with the analysis of behavioral, neurochemical, morphological, and electrochemical endpoints taken on aging rhesus monkeys. Dr. Hardy will be in charge of developing new MRI sequences for MRI data acquisition and MRI measurements of iron content. He is an expert on medical physics, especially MRI. Dr. Rayens will be in charge of the statistical analysis for all major endpoints of the project as well as help with the correlation of responses among the projects and among measurements. He is an expert on biostatistics and applied multivariate statistical methods. The specific aims of the Data Analysis Core are to: 1. advise all investigators in the Program Project on issues related to experimental design and data analysis, 2. perform the statistical analysis of the main endpoints in each of the projects, 3. provide quantitative assessments of each fMRI and anatomical MRI session recorded in Project by Zhang, and 4. correlate the findings among the projects.